Electron Microscopy Core

The NHLBI Electron Microscopy Core Facility has supported projects using the following techniques in the past year: 1. Fixation, embedding, ultra-thin sectioning and transmission EM digital imaging of tissues and cells. 2. EM immunocytochemistry, including immunogold localization of proteins and other antigens within and on the surface of cells by pre-embedding techniques. 3. Negative staining of large proteins, polymers and supramolecular structures as well as lipid and membrane vesicles for transmission EM imaging. 4. Fixation, critical point drying, sputter-coating and scanning EM digital imaging of small organisms, organs, tissues and cells, as well as other materials such as artificial matrices. In the past year, we have supported 26 projects for 17 principal investigators in the NHLBI/DIR: Stewart Levine, James Shelhamer: Autophagy in leukotriene D4-treated mouse macrophage cell line. Robert Kotin: Characterization of AAV preparations for in vivo gene transfer;Course of AAV formation in baculovirus-infected insect cells;Ultrastructure of Duchenne Muscular Dystrophy muscle in dogs. Cecilia Lo: Ultrastructure of cilia in humans with ciliary dyskinesia;Cilia ultrastructure in cardiac development mutants;Developmental defects related to sonic hedgehog signaling in cilia mutant mice. Rosa Puertollano: Regulation of mucolipin-1 induced lysosomal storage granule accumulation in Hela cells by LAPTM4a and 4b; Immunogold localization of novel mucolipin-containing organelles in cultured epithelial cells;Endosome and lysosome regulation by PI-4,5-P-4 Phosphatase Type I. Toren Finkel: Ultrastructural changes resulting from conditional knockout of ATG7 in pancreatic beta cells and skeletal muscle; Mitochondrial morphology in thymocytes of Bmi KO mice. Joel Moss: Lysosomes in liver of ARD1 knockout mice and cell lines. Robert Adelstein: Myocardium ultrastructure in myosin IIB conditional knockout mice. Nico Tjandra: Virus budding in possible internal compartments in transfected Cos cells Claire Waterman: Characterization of patterned fibronectin on acrylamide for cell culture;Characterization of a synthetic surface for cell adhesion studies. Jay Knutson: Characterization of gold nano-particles; Gold nano-particle penetration into tissue slices. Mark Knepper: Validation of urinary exosome assays by electron microscopy;Immunogold localization of aquaporin channel redistribution in cultured epithelial cells. Jennifer Lee: Characterization of liposome-protein interactions. Howard Kruth: Macrophage processing of LDL. Alan Remaley: Micro-RNA binding to HDL. Maurice Burg: Cytoplasmic membrane dynamics during hypertonic stress in Hela cells. Michael Sack: Mitochondrial morphology in Pink 1 knockout mice.